Disulfated polyamidosaccharide nanoparticles as a P-selectin targeting chemotherapeutic delivery system

ABSTRACT
Cancer is one of the leading causes of death worldwide, with metastasis being a prime culprit. Cancers
of the breast and lung are the two most common cancers today, and most fatal cancers for women. Non-small
cell lung cancer (NSCLC) diagnoses have risen 84% for women over the past 42 years while dropping 36% for
men; 20% of these female patients are lifelong non-smokers. The increase in non-smoker lung cancer is due in
large part to genetic mutations such as ROS1 and AKL fusions and EGFR mutations, all of which are
significantly more prevalent in women. These mutations are also more prevalent in late-stage NSCLC and
affect patient response to treatments, which can result in a longer opportunity for the cancer to metastasize.
Genetic mutations have also been shown to lead to uncommon sites of metastasis, which suggests alternative
mechanisms of dissemination. P-selectin (CD62P) is a protein upregulated on many types of tumor cells,
including breast and lung, and plays a crucial role in the dissemination of those cells around the body due to its
function mediating the rolling of cells and facilitating adhesion of blood cells to the endothelium of other organs.
In healthy cells the expression level of CD62P is constitutively low, while in tumor microenvironments such as
kidney, lung, and breast cancers, the protein is highly expressed and can be further induced via radiation
treatment, which is abscopal. Fucoidan exhibits nanomolar affinity for CD62P, and it is actively investigated as
a targeting moiety for drug delivery platforms. Unfortunately, given that fucoidan is isolated from the cell-wall
matrix of seaweed, there is high dispersity and structural irregularity within batches, along with large batch-to-
batch variability based on the environmental conditions the fucoidan is isolated from. Thus, there are changes
in sulfation and methylation of the monosaccharide units, leading to inconsistent binding affinity for CD62P. I
propose that a 3,6-disulfated polyamidosaccharide (disulPAS) will serve as a much-needed synthetic fucoidan
mimetic, retaining the biocompatibility of natural polysaccharides but with a tunable sulfation density, molecular
weight, and narrow dispersity. Further, binding studies on a library of disulPAS varying in molecular weight and
sulfation density will give insight into the metastasis mechanisms of genetically mutated NSCLC cells, and
nanoparticles made from amphiphilic disulPAS and loaded with paclitaxel will actively target metastasizing
cancer cells. In this work I propose that disulPAS will serve as a synthetic fucoidan mimetic, the
disulPAS synthesis can be optimized in molecular weight and sulfation density to create disulPAS
nanoparticles for the CD62P targeted delivery of chemotherapeutics to metastasizing cancer cells, and
optimal disulPAS formulations may vary based on the genetic mutations present in the cancer, giving
insight into the mechanism of metastasis in mutation-based NSCLC.

Public health relevance
Project Narrative While there are many drugs both approved and in clinical trials for the treatments of localized tumors, the metastasis of cancer and targeting of disseminated tumor cells remains an area of unmet need. P-selectin is expressed on the endothelium of many types of commonly metastasizing tumors, including breast and lung cancers, and is thus a strong candidate for targeted delivery of therapeutics. The specific and guided clinical awareness of this multi- disciplinary pre-doctoral training program is the chemical synthesis and subsequent evaluation of a novel synthetic fucoidan mimetic and P-selectin binder for improved chemotherapeutic delivery to metastasizing cells.